Core B - Technology Core

The objective of the Technology Core is to provide state-of-the-art, innovative -OMICs technologies for the
targeted and global characterization of Project samples in a quantitative, reproducible, and efficient manner. The
core brings together cutting-edge tools and the expertise of leading systems biologists in three critical areas: (1)
Proteomics led by Dr. Nevan Krogan at the J. David Gladstone Institutes; (2) Transcriptomics and Epigenetics
led by Drs. Chris Benner and Ivan Marazzi at the University of California, San Diego and the Icahn School of
Medicine at Mount Sinai; and (3) Viral Reverse Genetics led by Dr. Luis Martinez-Sobrido at the Texas
Biomedical Research Institute. The Technology Core will be responsible for processing and analyzing both in
vivo samples from infected patients and mice (Project 1) as well as ex vivo infected samples in primary and
immortalized cells (Projects 1 and 2). The generated data will be processed, analyzed and stored in
collaboration with the Data Management and Bioinformatics Core. Data integration will be performed by the
Modeling Core to discover key drivers of coronavirus infection, transmission, host response, and host tropism
as potential nodes for therapeutic intervention. Further integration of -OMICs data with longitudinal clinical data
derived from patient cohorts will identify biomarkers of disease severity. The Technology Core will provide
recombinant viruses (including reporter, deletion, and point mutation) and -OMICs services for essential
functional and mechanistic follow-up studies probing the molecular mechanism of the critical drivers identified in
each respective Project. This iterative cycle from networks-to-mechanism is driven by our effective collaborative
efforts that unites multiple labs to optimally leverage best-in-class -OMICs approaches that rely on high-level
specialized equipment and domain-specific expertise.
The Technology Core has the unique challenge of processing coordinated samples and generating and
integrating systems data spanning chromatin modifications and architecture, gene expression, protein
abundance, post-translational modifications, and protein-protein interactions. In the previous iteration (the
FluOMICs consortium), Drs. Benner and Krogan have successfully tackled these challenges and derived
standardized protocols for sample generation, processing, and analysis across different cores and institutes.
More recently, Drs. Marazzi and Martinez-Sobrido, who have already established relationships with FluOMICs
team members, joined new collaborative efforts to study coronaviruses. Formalizing this relationship as a single
core under the leadership of Dr. Krogan, an internationally recognized expert in the design and application of
systems biology approaches to interrogate host-pathogen interactions, the Technology Core is ideally
positioned to effectively coordinate Technology Core labs to implement previously developed pipelines under
FluOMICS 1.0 and 2.0 and develop new approaches for the accomplishment of SYBIL Aims.